Connecting epigenetic programming of T cells with molecular traits of the immune system in health and disease

PROJECT SUMMARY
Identifying causal disease variants and elucidating how they lead to chronic disease remain important
challenges in medicine. Genome-wide association studies have shown that polymorphisms associated with
different human chronic diseases such as multiple sclerosis, rheumatoid arthritis and type 1 diabetes map
predominantly to noncoding cis-regulatory regions of immune cells. Recent work has shown that a substantial
fraction of non-coding variants linked to autoimmune disease lie in cis regulatory elements (CREs) of T
lymphocytes, a subset of immune cells that play vital roles in preserving self-tolerance and preventing
autoimmunity. However, determining which specific genes are regulated by CREs remains a challenge due to
the temporal and spatial contexts in which they are modulate gene expression and the lack of suitable models
to assess their activity in a manner that preserves their native chromatin structure. Importantly, T cells from
autoimmune patients also exhibit marked changes in DNA methylation. However, the link between epigenetic
changes and disease-associated variants is unclear. Our work has shown that T cells undergo significant
epigenetic programming via DNA demethylation in the thymus and this programming is essential for long-term
gene regulation in T cells. Remarkably, we have found that CREs active during T cell development play a
critical role in modulating these epigenetic changes. Furthermore, we have shown that a significant number of
genes that have critical roles in regulation of signals received the T cell receptor, which is essential for proper T
cell function, are programmed in this manner. The goal of this proposal is to elucidate how CREs modulate
epigenetic programming in genes with long-term functionality during thymic development and to define their
contribution in chronic diseases. We propose a new model to test how human CREs in which disease-
associated variants are present, modulate gene expression during thymic development and affect long-term
epigenetic programming. We propose a new conceptual framework and mouse models to then investigate the
mechanisms by which these CREs alter T cell function and promote chronic disease. Finally, we will
investigate the involvement of newly discovered molecular factors that facilitate DNA demethylation during T
cell maturation in the thymus. Understanding these mechanisms not only offers crucial insights into the
aberrations of normal gene function in T cell driven diseases but also presents opportunities for the
development of innovative approaches to enhance treatments for these illnesses. The comprehensive
strategies outlined in this proposal will not only establish the foundation for future investigations into non-
coding disease variants in autoimmune disorders driven by T cells but also offer a conceptual framework and
new models for future investigations into disease-related variants that are prevalent in other cell types such as
B cells.
.

Public health relevance
PROJECT NARRATIVE Chronic diseases such as autoimmune diseases are genetically complex and it is hard to predict whether certain mutations increase disease risk and how they increase disease risk, especially when they are not present in DNA regions that directly code for proteins. In this proposal, we will utilize and develop holistic approaches to systematically investigate how specific regions of the genome affect the long-term gene function in T lymphocytes, a class of cells that are highly relevant in autoimmunity, and to delineate how these regions ensure that T cells remain fit and protect against disease. Once we define the importance of these genomic regions on long-term gene function, and unravel how they alter disease, we will be able to develop appropriate therapeutic strategies to reduce poor disease outcomes.